Targeting RNA Polymerase I Transcription Machinery in Chemoresistant Ovarian Cancer

PROJECT SUMMARY
Virtually every cancer that takes the life of a patient is due to innate or acquired chemoresistance. This
is especially true in epithelial ovarian cancer (EOC), in which most tumors are initially sensitive to platinum-based
chemotherapy, but most will recur and succumb to chemoresistant disease. To achieve durable cures we must
understand the molecular mechanisms of chemoresistance. Through in-depth analysis of multiple models of
matched pre- and post-chemotherapy (carboplatin/paclitaxel) ovarian cancers from treated patients, patient-
derived xenografts (PDX), and resistant cell lines, we have discovered and validated that chemoresistant tumors
have significant upregulation of the ribosomal biogenesis pathway. We have further examined efficacy of two
inhibitors of RNA Polymerase I (Pol I), the primary regulator of rRNA production. These agents, CX-5461 and
BMH-21, have significant (but frequently variable) activity against ovarian cancer cell lines and PDX models of
all histologies, and in many cases is even more effective in chemoresistant models. CX-5461 is currently in a
phase I trial, but we are the first to demonstrate and explore the particular susceptibility of chemoresistant cells
to targeting ribosomal biogenesis, and why this process might be key to developing chemoresistance. Several
questions remain unanswered, including whether targeting Pol I can kill the post-chemo microscopic remaining
population to achieve durable cures; how upregulation of ribosomal machinery enhances chemoresistance; what
transcriptome is activated by chemotherapy; whether the effects are specific to paclitaxel, carboplatin, or the
combination; and whether the hypothesized critical role of TP53 in the efficacy of these agents can allow
strategies to allow targeting Pol I to be even more effective. The overall objectives of this proposal are to
understand how upregulation of ribosome biogenesis allows cancer cells to survive chemotherapy, identify the
most effective setting in which to target Pol I as a therapy, and identify the best agents to use in combination
with Pol I for therapeutic synergy. To achieve these objectives, we will investigate in greater detail the
chemotherapy-induced differences in ribosome synthesis between the chemosensitive and chemoresistant cell
populations using multiple models, and identify how these differences are mediating Pol I inhibitor sensitivity.
Chemoresistant PDX models will be used to determine if Pol I targeting can prevent recurrence, or enhance
carbo/paclitaxel efficacy. We will investigate the differences between chemosensitive and chemoresistant cells
at the level of chromatin structure, occupancy of rRNA DNA transcription sites, and ribosomal organization. We
will utilize a 7,000-gene CRISPR library of druggable targets to identify candidate drugs to use in combination
with targeting Pol I. If the role of ribosomal biogenesis in chemoresistant cells can be better understood, it could
open the door to an entirely new approach to treating many cancers, and focus on the most deadly aspect of
cancer – evolution to a chemoresistant phenotype for which there is no cure.

Public health relevance
PROJECT NARRATIVE We have discovered through in-depth analysis of unique sets of matched samples from patients before and after carboplatin/paclitaxel treatment, chemosensitive/chemoresistant patient-derived xenograft (PDX) models, and platinum or taxane-resistant cell lines, that chemoresistant ovarian cancer cells have a preferential dependence on ribosomal biogenesis for their survival. Targeting ribosomal biogenesis with inhibitors of RNA Polymerase I (Pol I) are effective in eliminating chemoresistant cells, without damaging noncancerous cells at equivalent doses. This proposal will identify the optimal approach to target chemoresistant ovarian cancer cells with a new class of inhibitors, elucidate the fundamental mechanisms causing chemoresistant cells to be more dependent on ribosomal biogenesis than nonmalignant cells, and identify new targetable genes that can be used combination with Pol I inhibition for enhanced therapeutic effect.